Metabolic Syndrome, Periodontal Health, and the Oral Microbiome

Project Summary
Metabolic syndrome (MetS), a global epidemic that affects more than 1/3rd of the US adult
population, is a cluster of biochemical and physiological abnormalities that predisposes to Type
2 Diabetes (T2D) and Cardiovascular Diseases (CVD). Emerging evidence indicates that
Metabolic Syndrome (MetS), an adverse consequence of obesity, is associated with an increase
in the extent and severity of periodontitis. Periodontitis is a microbially induced chronic
inflammatory disease that destroys the supporting structures of teeth, eventually leading to tooth
loss and the severe form of the disease affects ~10% of the American adults. Although there are
narrative reviews and a handful of cross-sectional studies that suggest the association between
MetS and increased prevalence of periodontitis, the mechanism(s) behind these associations
have not been investigated.
Dysbiosis in the oral environment leads to periodontal disease, however, the mechanisms
of these disruptions and subsequent functional alterations in the oral microbiome of MetS patients
remain undefined. Therefore, our central hypothesis is that MetS creates an at-risk-for-harm
environment, even before the onset of clinical periodontal disease by altering the microbial
functions and metabolites. We will test our hypothesis by carrying out two aims: In Specific Aim
1, we will determine the effects of MetS on the oral metagenome, by comparing and quantifying
changes in microbial gene abundances and associated functional pathways between MetS and
controls, using a multi-arm, cross-sectional study design with whole-metagenome sequencing. In
Specific Aim 2 we will map the microbially-derived metabolites (the end products) in the
subgingival environment of patients with MetS using gas chromatography/mass spectrometry
(GC/MS) analysis. The expected outcomes of the proposed studies are the determination of
effects of MetS on the functional and metabolic landscape of the subgingival environment. We
anticipate that our integrative systems biology approach combined with clinical epidemiology will
lay the foundation for future mechanistic investigations. Driven by the startling statistics of
economic and health burden caused by the MetS in the backdrop of the prevalence of the
periodontal disease in the US adult population, we are proposing a much-needed study in a
severely under-explored area: the impact of Metabolic Syndrome on oral health. Our long-
term goal is to identify personalized, experimentally validated biomarkers/potential indicators of
health and future periodontal disease in this high-risk cohort.

Public health relevance
Project Narrative: About half of the American adults are diagnosed with periodontal disease while severe form of the disease affects 10% of the population, with the treatment costs estimated to be over a billion dollars annually. Recently, Metabolic Syndrome (MetS), a global epidemic that affects more than 1/3rd of the US adult population, is associated with an increase in the extent and severity of periodontitis. We are proposing a multi-arm, cross sectional, case-control study with integrated- omics approaches to identify the role of the oral microbiome and their associated functions that influence susceptibility to and development of the periodontal disease in this high-risk cohort.